The role of the protein C system in trauma induced coagulopathy and thromboinflammation: mechanisms and targeted therapy.

PROJECT SUMMARY: Trauma remains the leading cause of death for individuals aged 1 to 54, with a significant
proportion of these fatalities attributed to trauma-induced coagulopathy (TIC) and a dysregulated inflammatory
response, termed thromboinflammation. Advancements in resuscitation have lacked a mechanistic focus,
instead, focusing on mitigating the adverse effects of crystalloid fluids, optimizing the use of blood products, and
non-selectively addressing clot formation and fibrinolysis. Consequently, improvements in outcomes among
trauma patients have plateaued. Further, efforts have failed to address trauma-associated thromboinflammation,
which is the primary driver of late-stage morbidity and mortality. To date, there are no therapeutics to target post-
trauma thromboinflammation to our inadequate understanding of the mechanistic underpinnings. The protein C
system is a key mechanistic driver of TIC and its associated morbidity and mortality following injury and due to
its distinct dual anticoagulant and cytoprotective activities, APC both drives TIC development and mitigates
thromboinflammation. Thus, therapeutics targeting the protein C (PC) pathway could be ideal for trauma patient
management. Supported by our preliminary data, we propose that activation of PC after trauma is an acute
protective evolutionary response to preserve cellular function following severe injury, with the unfortunate
sequalae of this otherwise beneficial response being TIC. This evolutionary protective response to severe injury
is considered maladaptive, providing an early `too much of a good thing' response (cytoprotective AND
coagulopathic), which is followed by a late (`too little of a good thing') exhaustion of this response with resultant
dysregulated thromboinflammation and organ failure. We propose a dual APC -targeted approach, such that
pharmacologic APC-based cytoprotection will help to restore endothelial function and mitigate
thromboinflammation of trauma and inhibition of anticoagulant effects will help to curb bleeding and TIC. We are
now positioned to explore innovative pathways for mechanistic studies aimed at developing targeted therapies
to selectively modulate the protein C system, thereby preventing bleeding and treating thromboinflammation.
Here, new activity-selective nanobodies to APC and an engineered factor (F) V variant that bypasses APC
anticoagulant activity will be studied to counter the coagulopathy of TIC. Further, engineered 3K3A-APC with
minimal anticoagulant activity and full cytoprotective activity, and novel APC-mimetic cytoprotective PAR1 and
PAR3 derived agonist peptides will address thromboinflammation. Mechanistic and therapeutic exploration of
these novel compounds will address the clinical challenges of TIC and thromboinflammation thereby improving
both short and long-term survival among critically injured patients.

Public health relevance
PROJECT NARRATIVE Trauma and hemorrhagic shock results in trauma induced coagulopathy (TIC) and thromboinflammation which cause morbidity and mortality. This work focuses on the protein C pathway which links TIC and thromboinflammation. By understanding the mechanisms and dynamics of TIC and thromboinflammation we aim to develop targeted therapies to restore homeostatic balance to the protein C system to stop bleeding and reequilibrate inflammation thereby improving outcomes for trauma patients.